Optimizing Opioid Use Disorder Treatment in Prisons: Strategies for Diagnosis and Shared Decision-Making

PROJECT SUMMARY/ABSTRACT
People released from prison have 40 times greater risk of dying of opioid overdose in the first 2 weeks after
release than the general population. Initiating medication for opioid use disorder (MOUD) during incarceration
reduces that risk substantially, but most people in prison with opioid use disorder (OUD) do not receive MOUD.
The objective of this work is to test practical, scalable strategies to identify OUD in prisons and successfully
engage people with OUD in MOUD treatment. This study will take place in the Washington state prison system,
a largely rural system in a western state. This project will test two distinct strategies: 1) A practical approach for
screening for and diagnosing OUD: Diagnosing OUD is a prerequisite to offering treatment, but identification of
OUD in prisons is more challenging than in jails and non-carceral medical settings. There is immense need for
a brief (1-2 item) OUD screening tool as well as an OUD-specific diagnostic tool that have been validated in
prisons. This project will validate (a) a two-item OUD screening tool, intended for population-based screening,
and (b) an 11-item diagnostic DSM-5 criteria OUD symptom checklist. Both have been adapted for prison in the
research team’s formative work in Washington prisons and extensive prior work developing and validating tools
for non-carceral primary care settings. The tools will be validated in a sample of 524 recently incarcerated people
against a reference standard of a clinical interview. 2) Shared decision-making for OUD treatment options: After
people are diagnosed with OUD, they need to make decisions about treatment. Treatment that aligns with an
individual’s values and preferences may improve engagement and treatment outcomes. Shared decision-making
(SDM) has been shown to increase treatment engagement for OUD and other behavioral health conditions. SDM
involves informing patients that they have a choice, reviewing treatment options, and discussing their prefer-
ences to collaboratively select a treatment. SDM can be delivered in a single session by a nurse, which aligns
with protocolized, nurse-led prison health care models. Incarcerated people have limited autonomy but retain
autonomy over most health care decisions, including whether to start MOUD and which medication to start.
Prison, however, presents unique opportunities and challenges for SDM. This project will conduct a hybrid type
1 implementation-effectiveness encouragement trial of SDM for OUD treatment in a prison, randomizing people
who are approaching release to be offered brief, nurse-led SDM or to receive usual care. The primary trial out-
come is receipt of MOUD at release. Secondary outcomes include post-release mortality, post-release receipt of
MOUD, and disciplinary violations in prison; SDM cost and implementation outcomes—acceptability and feasi-
bility—will also be assessed to facilitate scale-up of SDM, if effective. Public Health Impact. At least 180,000
people in prison have OUD and are at high risk of post-release death. The proposed research tests practical
tools to enable carceral systems to provide high-quality OUD care to this high-risk population.

Public health relevance
PROJECT NARRATIVE Initiating medication for opioid use disorder (MOUD) in people with opioid use disorder (OUD) during incarceration can reduce the very high risk of opioid overdose immediately after release. This study tests two practical strategies to support OUD treatment during incarceration in prison: 1) Validation of both a two-item OUD screening tool and 11-item diagnostic opioid symptom checklist and 2) A trial of nurse-led shared decision-making about MOUD options.